Admin Core

SUMMARY/ABSTRACT
The Administrative Core will provide oversight and facilitate programmatic goals, fiscal management,
communication and compliance with current NIH and institutional policies and guidelines for the HIPC Center
entitled “Systems immunology profiling of respiratory viral infections in vulnerable populations” This core will
serve both Research Projects, the Clinical Core, the Data Management & Analysis Core, the Genomics Core,
and the Adaptive Phenotyping Core. It will also provide oversight to ensure that scientific objectives are met,
including defining milestones, monitoring progress, and facilitating resource allocation. This core will also
facilitate communication between project and core leaders, organizing the kickoff meeting, regular monthly
meetings, and special topic meetings as needed. It will also serve as the direct conduit by which the HIPC
Center communicates with the broader HIPC network and HIPC program staff at NIAID. This core will also be
responsible for facilitating dissemination of research findings to the scientific community and the general public
by assisting with preparation of manuscripts and presentations. The Administrative Core will also provide day-
to-day administrative and fiscal management for each project and core including monitoring and tracking
expenditures, fiscal accountability, staff training, and ensuring compliance with NIH regulations. The
Administrative Core will be assisted by a leadership council comprised of the two Research Project Leads, the
Clinical Core Lead and the Data Management & Analysis Core Lead. An Administrative Core Manager, and a
Grants and Contracts Analyst will be responsible for day-to-day operations, and fiscal management and
accountability, respectively. BRI has supported the administration of several large program projects and its
administrative personnel is experienced and well-equipped and to manage the operations and oversight of this
consortium. Overall, the Administrative Core will coordinate all administrative activities ensuring that the HIPC
Center is integrated, synergistic, and focused on achieving its scientific goals.